The Examination of Infection Prevention and Crowding in the Emergency Department

DESCRIPTION (provided by applicant): Healthcare associated infections (HAIs) are a leading cause of death in the United States, despite being largely preventable. HAIs can be significantly reduced through the use of guideline-based infection prevention processes, e.g., aseptic technique during the placement of invasive devices and hand hygiene during patient care. In the emergency department (ED) care setting, millions of invasive devices are placed each year and numerous opportunities for hand hygiene exist. In recent years, HAI prevention in the ED has become more paramount given the growing problem of ED crowding. ED crowding is a major patient safety concern associated with significant mortality and poor care quality. During times of ED crowding, patients' needs are often met with insufficient resources. Patients commonly receive care from understaffed healthcare providers in cramped, unsafe settings, which likely affect guideline-based care. However, no study has examined infection prevention in the context of ED crowding. Guided by Donabedian's framework of healthcare quality, this study aims to determine the relationship between ED crowding and patients' receipt of guideline-based infection prevention processes, i.e., aseptic technique during urinary catheter, peripheral venous catheter, and central venous catheter placement, and hand hygiene during care. The proposed study will be conducted in the ED of an urban, tertiary hospital in northern Manhattan. Direct observations of infection prevention processes will be representative of all shifts and days of the week. Processes data will be recorded on psychometrically sound checklists, which reflect current evidence- based guidelines. Checklists include those developed by the World Health Organization and adapted from hospital policies. Observers will undergo rigorous testing throughout the course of the study to ensure high levels of inter-rater reliability (kappa >0.9). More than 900 observation periods will be included in analyses. Checklist data will be aggregated during each observation period and an adherence score will be calculated. Adherence scores will be the main variable of interest. ED crowding will be the primary predictor variable and will be measured using a validated, standardized instrument at the start of each observation period. Depending on the distribution and spread of data, a multivariate linear or logistic regression model will be used to analyze the relationship between ED crowding and patients' receipt of guideline-based infection prevention care. The short term goal of this study is to demonstrate the need for improved infection prevention in the ED, with the ultimate goal of facilitating interventions that improve evidence-based practices and prevent HAI. As such, this study is well aligned with the National Institute of Nursing Research's goal of disease prevention. Further, the receipt of this award will attest to NINR's mission to train the future generation of nurse scientists. The applicant is a BSN to PhD student eager to become a nurse scientist and improve care quality in the ED.

Public health relevance
PUBLIC HEALTH RELEVANCE: Healthcare associated infections (HAIs) are a major public health concern, despite being largely preventable. Millions of patients utilize the emergency department (ED) each year. During periods of ED crowding, patients are often exposed to unsafe conditions, which likely inhibit their receipt of guideline-based infection prevention care. This study will be the first to examine infection prevention in the context of ED crowding and will foreseeably demonstrate the need for improved evidence-based practices. __SpecificAimsTextDelimiter__ B.2 Specific Aims Healthcare-associated infections (HAIs) cause significant patient morbidity and mortality,1 despite being largely preventable.2 HAI prevention has been recently highlighted by the United States (US) Department of Health and Human Services as a National Action Plan3 and by the Joint Commission as a 2012 National Patient Safety Goal.4 It is estimated that a majority of device-attributable HAIs are preventable through guideline-based aseptic technique processes.2 Further, guideline-based hand hygiene processes are the most effective method to prevent the global spread of infection.5,6 This is of particular importance in the emergency department (ED) care setting, where millions of invasive devices are placed, such as urinary catheters, peripheral venous catheters, and central venous catheters,7-10 and numerous opportunities for hand hygiene exist.11 Infection prevention in the ED is especially relevant given the dramatic rise in ED utilization.12 Millions of individuals access healthcare in the ED each year, and these figures are rapidly increasing.13 In fact, the ED is the major portal of hospital admissions, responsible for 55% of inpatients.14 The increased usage of the ED among patients has contributed to the growing problem of ED crowding.15 ED crowding is an important patient safety concern,15 associated with significant patient mortality16 and poor quality of care.17 ED crowding is defined as periods in which patients' needs for care in an ED are met with insufficient resources.15,18 Studies show that ED crowding is associated with decreased patient satisfaction,19 higher rates of patients who leave the ED without care,20 and increased patient length of stay.21 During these times, patients commonly receive care in shared treatment areas such as hallways,22 receive frequent interruptions to their care,23 and are treated by overwhelmed and hurried healthcare workers.24 These conditions have impinged on patients' receipt of guideline-based care, specifically in regards to timeliness of treatment.25 It is likely that these conditions also impact patients' receipt of guideline-based infection prevention processes. However, studies of infection prevention in the ED have been narrow in number, scope, and quality. In fact, no study has examined the relationship between ED crowding and patients' receipt of guideline-based infection prevention care in the ED. Guided by Donabedian's model of healthcare quality, and building upon the research and expertise of my mentors, I propose to conduct a descriptive study in the ED of NewYork- Presbyterian/Columbia University Medical Center, a large, urban, academic medical center located in northern Manhattan. This study will be the first to examine the relationship between guideline-based infection prevention processes in the ED and ED crowding. Patients' receipt of guideline-based infection prevention processes will be directly observed and assessed through psychometrically sound checklists. Checklist data will be aggregated at each observation period and will be used to calculate an adherence score. Adherence scores will be the main study outcome measure. ED crowding will be the primary predictor variable. A valid and reliable scale26 will be used to measure ED crowding at the start of each observation period. The proposed research will address the following aim: Aim: Determine the relationship between ED crowding and patients' receipt of guideline-based infection prevention practices, i.e., aseptic technique during the placement of urinary catheters, peripheral venous catheters, and central venous catheters, as well as hand hygiene during patient care. Hypothesis: Higher levels of ED crowding will be associated with lower adherence scores. The proposed study is timely and pertinent given the millions of invasive devices that are placed in the ED, the expansive numbers of patients who seek care in this care setting, and the conditions that patients are exposed to during periods of ED crowding. Study results will foreseeably demonstrate a relationship between guideline-based infection prevention processes and crowding; highlight the need for improved evidence-based infection prevention care; and serve as a basis for further infection prevention research in the ED care setting. The immediate goal of this study is to demonstrate the need for improved infection prevention care in the ED, with the ultimate goal of facilitating interventions that improve practices and prevent HAIs. Therefore, this study is well aligned with the National Institute of Nursing Research's (NINR) mission of disease prevention.27 Moreover, the receipt of this award will attest to NINR's commitment to train future nurse scientists and the Institute of Medicine's Future of Nursing recommendation to increase the number of nurses with doctorates.28 The applicant is a BSN to PhD student whose professional goal is to become a nurse scientist at a research intensive university, dedicated to improving the quality of care rendered in the ED setting. The receipt of this award will facilitate and enhance her research training and future academic career.